2022 Chemistry & Biology of Peptides Gordon Research Conference & Gordon Research Seminar

Summary/Abstract The 2022 Chemistry and Biology of Peptides Gordon Research Conference (CBP-GRC) will highlight the exciting diversity of peptide science. Attendees will engage in discussions regarding scientific discoveries, challenges and advances in the design, synthesis, characterization, and translation of peptides. We have created an innovative and cutting-edge program encompassing sessions focusing on recent developments in chemical biology and organic synthesis complemented with sessions covering topics such as artificial intelligence (AI), vaccine development, immunology, natural and unnatural products, advances in green chemistry, biosynthesis, and novel technologies. To engage the audience and promote discussion, session chairs will give an overview of the broader field in each session to bring the audience together before the session speakers deliver their lectures. Furthermore, to increase cross-talk amongst scientists, sessions including “peptide mash-up” and the “future of peptides” will bring together scientists from vastly different fields (e.g. green chemistry, drug discovery, and structural biology) in a single session encouraging and stimulating our attendees to think outside of their own scientific boxes and promote collaboration across multiple disciplines. In 2022, the successful and well attended Power Hour will continue, highlighting the challenges women and minorities are still facing, as well as discussing solutions and progress toward equity. Altogether, this conference provides a collegial environment where emerging scientists present their work alongside world leaders in the field and the conference is the highlight of the peptide community conference calendar. The graduate and postdoctoral student-run Gordon Research Seminar (GRS), held in conjunction with the related GRC, will provide opportunities for graduate students and postdoctoral scholars to foster meaningful connections by discussing their research and networking with their peers. The student- facilitated seminar, as well as the poster session, are designed to foster communication between students and form relationships which are then leveraged at the GRC. In addition, the GRS includes a career panel in which three mid-to-late career professionals provide insights and strategies on various career paths. The objective of the CBP-GRC is to provide opportunities to deepen the impact of peptide science on healthcare and technology through scientific communication and collaboration while actively prioritizing a diversified community and the involvement of underrepresented minorities. This goal will be achieved by actively inviting speakers and session chairs from diverse backgrounds and career experience as well as developing a scientifically innovative and diverse program.

Public health relevance
Narrative Peptides are molecules integral to human biology and medicine that are exciting leads for the development of novel medical diagnostics, therapeutics, and vaccines. This conference will bring together world-class leaders and early stage investigators to advance peptide research in the 21st century.